Possible treatment of cocaine craving and relapse by memory erasure

DESCRIPTION (provided by applicant): The central problem in the treatment of addiction in general and cocaine in particular, is high rates of relapse to drug use after periods of forced or self-imposed abstinence. We suggest testing a new method for reducing addiction, which is based on intervention with memory processing, in a rat model of 'incubation of cocaine craving'. Our preliminary results indicate that an electrical stimulation of the lateral habenula lead to reward devaluation and signals the rat to stop longing for gratifying circumstances. Recent pieces of information may elucidate the molecular mechanisms underlying the effect of electrical stimulation on drug addiction: (i) processes of learning and memory underlie the shift in drug intake to an habitual stage (ii) activation of the DNA binding protein PARP-1 is required for long term memory formation during learning (iii) PARP-1 is activated in response to depolarizing electrical stimulation, and its activation mediates the expression of immediate early genes taking part in memory processing, (iv) and (v) drug addiction is accompanied with PARP activation in brain regions that have been associated with addiction. In view of these findings, we suggest (1) a possible role of PARP activity in cocaine relapse (2) electrical stimulation that teach the animal to devaluate a previous rewarding signal will involve alterations in PARP activity, and (2) a possible effect of memory erasure by PARP inhibitors on mechanisms that underlie cocaine relapse. There is scant preliminary data for this highly novel hypothesis. However, we gained some preliminary but significant data that support our hypothesis. Proving this hypothesis is expected to have a substantial impact on current concepts, and to offer a novel therapeutic approach for cocaine addiction. PUBLIC HEALTH RELEVANCE: No satisfactory treatment for the prevention of both addiction and the relapse of cocaine usage is currently available. As such, the primary significance of this study will be the adaptation of electrical stimulation and the use of PARP inhibitors to prevent relapse of drug usage. Although scant preliminary data exists for the novel hypothesis suggesting that memory processing underlies cocaine relapse, by our elucidating molecular research proving this hypothesis, we expect to make a substantial impact both on current concepts and the delivery of a novel therapeutic approach for preventing cocaine relapse.

Public health relevance
Public Health Relevance Statement No satisfactory treatment for the prevention of both addiction and the relapse of cocaine usage is currently available. As such, the primary significance of this study will be the adaptation of electrical stimulation and the use of PARP inhibitors to prevent relapse of drug usage. Although scant preliminary data exists for the novel hypothesis suggesting that memory processing underlies cocaine relapse, by our elucidating molecular research proving this hypothesis, we expect to make a substantial impact both on current concepts and the delivery of a novel therapeutic approach for preventing cocaine relapse.